Causal Inference of Disease-Relevant Regulatory Networks

DESCRIPTION (provided by applicant): The primary objective of this proposal is to develop novel statistical methods to identify specific disease- relevant regulatory networks. Such network/systems biology based methods are essential for understanding the role of genes in complex human disease, and have a broad application in areas such as cellular function underlying the disease, drug development, and disease classification. Based on our published works on Graphical Models, we will develop such systems-biology based statistical methods that combine genotype, gene expression, and clinical phenotype data to establish causal disease-related gene networks, through the following three interrelated Specific Aims. Each Aim will focus on a different biological problem. In Aim 1, we propose a novel statistical framework using naturally occurring DNA polymorphisms as randomized perturbations in lieu of experimental perturbation, to effectively infer the causality within the networks for better understanding for network dynamics. First, we perform a global search of disease-relevant epistasis network. Second, we zoom in and focus on the partial networks or modules related to genes of interest based on literatures or previous GWAS results. At next stage we introduce the effect of genotypes as randomized perturbation and establish the relevant eQTL and their effects on the modules. Finally, if the SNP effects are strong enough we can use the information to orient the edges within the network and infer causality and directionality. We will apply our method on two asthma cohorts to identify specific regulatory networks associated with asthma susceptibility and exacerbation. For Aim 2 we will develop novel methods for association between regulatory networks and disease subtypes based on phenotypic networks. First, we will develop a model for building a phenotypic network with multiple correlated disease phenotypes. Next we will tests for association between regulatory networks and different patterns of correlations among phenotypes. Finally, we will use the information from the regulatory networks and their correlations with different phenotypic network patterns for identification of different disease subtypes. We will apply the method on the COPDGene data set to identify regulatory networks associated with different COPD subtypes and phenotype patterns. Aim 3 will be focus on development of novel methods for network pharmacology, in particular, identification of specific networks/modules associated with drug use and its effects on patient outcomes. For that purpose we will consider drug use and treatment plan as pertubations, and develop a model that describes the causal relationship between regulatory networks, treatments and clinical phenotypes. We will apply the method on gene expression data from immortalized B-cells treated with Dexamethasone or sham to identify specific networks/modules associated with inhaled corticosteroids (ICS) use and their effects on asthma patient outcomes. We believe the proposed method will give more insight to the underlying biology of differential drug response and lead to development of more effective treatment plan for patients.

Public health relevance
Project Narrative The K99/R00 grant proposes to develop novel statistical methods for identification of specific regulatory networks associated with complex genetic diseases. The proposed methods will give better understanding of the molecular processes underlying cellular function, and their relation with disease pathogenesis, effectiveness of treatment, and other health outcomes. Such information is essential for developing novel therapy and more effective treatment plan for patients, thereby improving public health. __SpecificAimsTextDelimiter__ Specific Aims In recent years network models of genomic data have been frequently applied for characterization of complex interactions among genes and phenotypes [1-3]. Specifically, the regulatory systems of a cell have been effectively described by networks, providing better understanding of the molecular processes underlying cellular function, and ultimately improving our understanding of disease pathogenesis [4-6]. Though such systems biology based methodology for complex genetic diseases has been an active research area and many analytic approaches have been proposed [7-12], the identification of specific disease-relevant regulatory networks, particularly using human rather than model organism data, remains a challenging problem. For example, establishing causal relationships usually requires experimental perturbations (e.g., gene knockout), which are generally not feasible in human studies. In our previous work we have successfully applied a Gaussian graphic model to identify complex networks based on both genotyping and gene expression data. We also developed a method to quantify epistatic (gene- gene) interaction across different disease states, demonstrating the utility of such approaches for the identification of critical disease loci. We now propose to combine and extend these methods to more efficiently identify disease-associated functional genetic variation and their associated gene networks. We hypothesize that our novel approaches will identify critical regulatory variants that underlie complex diseases, and we propose the following three interrelated but independent specific aims. Each aim involves development of new statistical methods to solve different general problems, as well as proof-of-principle application work on specific diseases to demonstrate the advantages of the new methods. In all three aims, the performance of our methods will be evaluated using simulated data sets to compare the newly developed methods with currently available methods. Specific Aim 1: Development of novel methods for identification of disease-relevant regulatory networks based on randomized genetic perturbation data We propose that, in the absence of experimental perturbation data, we consider naturally occurring DNA polymorphisms as randomized perturbations, and use the combination of genotyping and gene expression data simultaneously to identify the causal regulatory influences between genes to better understand network dynamics. We will develop a multi-step statistical framework that combines genotype, gene expression, and clinical phenotype data to establish disease- associated gene networks. This framework will accommodate various sources of omics data, will integrate a priori structural and functional data (such as Gene Ontology (GO)), and will be able to infer causal relationship among genes. We will apply the method on existing genotype and gene expression data sets from Childhood Asthma Management Program (CAMP) and The Asthma BioRepository for Integrative Genomic Research project (Asthma BRIDGE). We anticipate the new method will identify specific asthma-associated regulatory networks that replicate across multiple populations. Specific Aim 2: Development of novel methods for associations between regulatory networks and multiple correlated disease phenotypes We hypothesize that many distinct patterns of disease phenotypes are manifestations of different disease subtypes and the disease-relevant regulatory networks identified in Specific Aim 1 might affect each subtype differently. Instead of testing for association with each phenotype individually, we will develop a model for building a phenotypic network with multiple correlated disease phenotypes, and tests for association between regulatory networks and different patterns of correlations among phenotypes. We will apply the method on the COPDGene data set to identify regulatory networks associated with different COPD subtypes and phenotype patterns. Specific Aim 3: Development of novel methods for network pharmacology: identification of specific networks/modules associated with drug use and its effects on patient outcomes We hypothesize that certain interactions between drug targets and other cellular components could lead to treatment failure and adverse outcomes. To investigate the effects of these interactions, we will develop a model that describes the causal relationship between regulatory networks, treatments and clinical phenotypes. We will apply the method to gene expression data from immortalized B-cells treated with Dexamethasone or sham to identify specific networks/modules associated with inhaled corticosteroids (ICS) use and their effects on asthma patient outcomes. We anticipate that out new methods will give greater insight into the underlying biology of drug reactions and lead to better predictive models for drug use. This proposal addresses an important scientific question: the role of genes in complex genetic diseases in the context of the regulatory systems in which they are involved. In addition, the proposal is based on the principal investigator's earlier work and his solid background in statistics and computing, and will prepare him to become an independent investigator in statistical genetics and systems biology. The proposed methodology has great potential to identify dysfunctional regulatory networks for many complex genetic diseases and thus lead to better understanding of these diseases.